WNK1/OSR1 axis in Hippocampal Insulin Signaling, Glucose Metabolism and Age-related Cognitive Dysfunction

Abstract
This proposal aims to provide crucial training for my long-term career plan to examine WNK1/OSR1 signaling
mechanisms contributing to neuronal metabolic alterations underlying the pathogenesis of age-related cognitive
impairment in dementia. Alzheimer’s Disease (AD) is the leading age-related cause of dementia, characterized
by progressive cognitive decline and neuropsychiatric symptoms. New research in animal models suggest that
neuronal insulin resistance disrupts insulin signaling and glucose utilization by the hippocampal neurons that
regulate cognition and contribute to pathogenesis of diseases such as AD. Yet, the exact molecular mediators
regulating insulin signaling-mediated glucose uptake by the hippocampus and their roles in cognitive processes
remain to be fully elucidated. I propose to investigate the contributions of protein kinases WNK1/OSR1 in
hippocampal insulin signaling, sortilin-mediated glucose transporter-4 (GLUT4)-dependent glucose uptake and
cognitive function. Although With-No-lysine (K) 1 (WNK1) and its substrate Oxidative Stress Responsive 1
(OSR1) are implicated in multiple diseases exhibiting cognitive and psychiatric impairments, the underlying
mechanistic details involved are not known. My unpublished preliminary data highly suggest upregulated
hippocampal WNK/OSR1 in cognitive deterioration via inhibition of insulin/AKT signaling, OSR1/sortilin-
dependent GLUT4 trafficking and glucose uptake. My data also suggest negative WNK1-AKT crosstalk and
disruption of this intricately controlled WNK1-AKT axis predisposes mice to metabolic dysfunction, which is
reversed upon inhibition of WNK1 downstream signaling. Disruption of insulin/AKT signaling also underlies
cognitive dysfunction in insulin resistant states in an age-dependent manner. These findings point to chronically
enhanced hippocampal WNK1 signaling in the pathogenesis of cognitive deterioration in insulin resistant states
and aging. I will test these hypotheses in this proposal. For this, I will acquire crucial training in insulin signaling
pathways, neuroscience, behavioral physiology, and neuropathology during the K99 phase of this proposal to
complement my previous training in metabolic pathophysiology, biochemistry, WNK1/OSR1 kinase biology, cell
and molecular biology. I will be mentored by a leader in insulin signaling- Dr. Melanie Cobb, neuro-framework
underlying metabolism and behavior- Dr. Jeffrey Zigman, molecular basis of memory- Dr. Kimberly Huber,
synaptic trafficking- Dr. Ege T. Kavalali, aging and mechanisms of AD pathogenesis- Dr. Ilya Bezprozvanny.
This proposal harnesses the commitment of the Peter O’ Donnell Jr. Brain Institute, Department of Neuroscience,
Department of Pharmacology, Mouse Behavioral Core facility, and the overall scientific training environment of
a world-class research institution at UTSW. Establishing a unique skill set in insulin and WNK1/OSR1 signaling
pathway in addition to metabolism, neuroscience, behavioral physiology, and neuro-pathophysiology, will
support my transition to an independent research academic position and will lead to the discovery of molecular
mediators underlying neuronal metabolic disruption in age-related cognitive impairment in diseases such as AD.

Public health relevance
New research in animal models suggest that neuronal insulin resistance disrupts insulin signaling and glucose utilization by the hippocampal neurons that regulate cognition and contribute to the pathogenesis of diseases associated with age-related cognitive impairment such as Alzheimer’s Disease (AD). WNK1/OSR1 kinases cross-talk with the insulin signaling pathway and are associated with diseases exhibiting cognitive dysfunction, yet, the underlying mechanistic detail by which WNK1/OSR1 signaling mediates insulin-dependent glucose uptake by the hippocampus and leads to the development of cognitive decline remain to be fully elucidated. To address this problem, the proposed work will combine kinase signaling biology, cell biology, metabolic and neurobehavioral physiology approaches to reveal the hippocampal WNK1/OSR1-dependent mechanisms by which insulin signaling mediates glucose metabolism and cognitive processes which go awry in insulin resistant states and aging (normal and AD-associated).